Development and Persistence of Tissue-Level Musculoskeletal Deformity Following Brachial Plexus Birth Injury

Project Summary
Brachial Plexus Birth Injury (BPBI) is a neuromuscular injury that causes lifelong arm impairments and
deformities in the glenohumeral joint which restricts mobility of the upper limb. Little is known about the
progression of bone and muscle growth in the postnatal period following BPBI. The parent grant explores key
drivers of deformity progression including the timeline of development and resultant functional effects through a
rat model consisting of different injury locations and unloading (preganglionic and postganglionic neurectomy,
disarticulation, and sham groups). The primary hypothesis is that the key driver in BPBI bone deformity is the
mechanical environment due to impaired longitudinal growth of paralyzed muscle and altered active functional
loading beginning shortly after injury. The proposed work will further the parent research by investigating active
loading of the glenohumeral joint during functional gait in a rat model. Bone readily adapts to its mechanical
environment, so analysis of its organized microstructures would also provide insight to key mechanical drivers
of microstructural deficits. Supplement Aim 1. Determine how limb loading is altered during functional gait
following BPBI. Rationale: Spatiotemporal characteristics of gait are substantially and differentially altered
during walking in rats following pre- and postganglionic neurectomy. However, the forces experienced on each
limb at the ground and on the developing glenohumeral joint are unknown and are likely important drivers of
glenohumeral development. Supplement Aim 2. Determine how active limb loading during functional gait
drives morphological and microstructural changes in the glenoid. Rationale: Our unique co-simulation
computational model of glenohumeral growth and function has been used to directly relate specific deformity
and contracture features to isolated changes in passive muscle force, active range of motion, and biological
growth rate; however, actual limb usage and its mechanical relationship to bone material properties and
trabecular organization has not yet been explored. Altered gait and limb loading during walking and running after
neurectomy will be evaluated to explore how limb usage and loading is affected by BPBI. Spatiotemporal motion
data and ground contact forces will be recorded for each animal and compared among groups. Resultant gait
data will be integrated into the computational simulation of glenohumeral loading and adaptation during active
limb function following BPBI. Tissue properties will be validated using micro-computed tomography (micro-CT)
images of the internal bone density and microstructure of the scapula and humerus collected under the R01
project and used to identify the portion of bone response due to active loading. A micro-CT-based micro-scale
finite element model will provide tissue stress and yielding patterns to elucidate loading-driven adaptations in
trabecular organization. The proposed supplement work will advance the originally planned modeling approach
by including dynamic limb loads and new methods to actively predict bone material property changes and
trabecular organization adaptations over the time of limb development.

Public health relevance
Project Narrative The progression of bone and muscle growth after brachial plexus birth injury is not well defined; therefore optimal clinical treatment and time of intervention is unclear. Through the parent and supplement studies, rat models and musculoskeletal modeling will uncover key drivers of glenohumeral bone deformity development.